CREATE GUIDE TO DATA FILES OF CHILD HEALTH STUDIES

Prepare an organized computer file and users' manual of the data collected as part of the Child Health and Development Studies which has longitudinal data on approximately 20,000 women and their offspring.